Configuration-specific cofactors of Oct4

PROJECT SUMMARY
Within the same cells, different target genes are frequently differentially regulated by the same transcription
factor. While distinct chromatin neighborhoods and co-bound factors are known to alter cofactor association
and hence transcription output, the role of DNA binding modality or transcription factor conformation in these
processes is far less clear. The transcription factor Oct4 is a master regulator of pluripotency with key roles in
early embryonic development, reprogramming and germ cell specification. Gaps in our understanding of Oct4’s
functions limit our ability to reprogramming efficiency, our ability to more sculpt differentiation in vitro, and our
ability to target Oct4 in different diseases. The fundamental hypothesis for this proposal is that the transcription
factor Oct4, bound to DNA in different configurations, recruits different cofactors resulting in distinct
transcription outputs. Oct4 can bind to DNA in different configurations depending on the specific DNA
sequence recognized. Using an affinity purification/mass spectrometry approach, we identified transcription
cofactors whose affinity for Oct4 is altered by the DNA sequence. One of these is the HBO1-Jade1 histone
acetyltransferase complex, which binds preferentially to Oct4 homodimers associated with binding elements
known as a MOREs (More palindromic Octamer-Related Elements). We recapitulated this result using purified
proteins, affording us the opportunity to conduct structure/function studies. MORE sites are present in a unique
class of broadly expressed genes in which Oct4 prevents inhibition that would otherwise be caused by
oxidative stress, e.g. the oxidative stress associated with blastocyst implantation. The HBO1 complex
acetylates multiple histone H3 and H4 lysines with little specificity, however in the context of Oct4 bound to a
specific DNA site near a nucleosome, we found that Oct4 recruitment of HBO1-Jade1 resulted in specific
enhancement of H3K9 acetylation, a key transcription activation mark. Our goals with this project are threefold:
to identify the key features of the configuration-dependent interaction between Oct4 and the HBO1 complex
(Aim 1), to determine if HBO1-Jade1 is associated with MORE-containing Oct4 target genes in pluripotent cells
(Aim 2) and to determine the structure of Oct4 dimers bound to MORE sites in complex with HBO1-Jade1 (Aim
3).

Public health relevance
PROJECT NARRATIVE Relevance: Induced pluripotency has great potential for regenerative medicine, but gaps in our understanding of Oct4’s transcriptional functions limit both reprogramming efficiency and our ability to more efficiently sculpt in vitro differentiation. Studying the biochemistry of Oct4 will therefore likely generate multiple significant breakthroughs and have significant public health relevance.